Functional assessment of TprC/D and TprK proteins of syphilis causing spirochete, Treponema pallidum

SCIENTIFIC ABSTRACT
Syphilis has an estimated global prevalence of 36M cases, with more than 11M new infections occurring
per year around the world. In the United States alone, the number of cases of infectious syphilis has steadily
increased since 2000, indicating that this disease is still a public health concern, particularly considering that it
can lead to serious neurological and cardiovascular sequelae. Understanding the biological function of the outer
membrane proteins (OMPs) of the syphilis agent, Treponema pallidum subsp. pallidum (T. pallidum), is one of
the greatest challenges in the study of syphilis pathogenesis. Progress towards functional characterization of
OMPs is hindered by the lack of an independent, pure culture system for T. pallidum, genetic intractability of the
pathogen, the need to use of rabbits for bacterial propagation, the paucity of OMPs in T. pallidum outer
membrane, and the fragility of this cellular compartment. Despite so many limitations, undertaking the study of
T. pallidum OMPs can greatly enhance our understanding of the role of these virulence factors in syphilis
pathogenesis and even provide important clues on new approaches to successfully control syphilis, such as by
developing a protective vaccine. Twelve of putative OMPs/virulence factors belong to the T. pallidum repeat
(Tpr) family, which are a group of highly immunogenic proteins predicted to be homologous to the Treponema
denticola (T. denticola) major sheath protein (Msp), a surface virulence factor with porin and adhesin properties.
Limited or no experimental evidence is available until now regarding functions of various Tprs. Based on
homology to Msp, structural models for the Tprs and our preliminary data, we hypothesize that several Tprs
also have dual roles as adhesins and porin transporters. T. pallidum and Borrelia burgdorferi, which causes
Lyme disease, are physiologically and structurally related spirochetes. Unlike T. pallidum, B. burgdorferi can be
genetically manipulated and transformed to express selected Tprs as if they were constituents of its OM. The
validity of the surrogate system to study Tprs is supported by our preliminary data showing that when TprD2 and
TprK are expressed on the surface of a non-infectious and poorly adherent B. burgdorferi strain, these proteins
enhance adhesion to Glioma and epithelial cells and facilitate amino acids and peptides uptake. Here, we plan
to further test our hypothesis and establish function of these important virulence factors by using both our well-
tried B. burgdorferi, as well as the T. denticola msp mutant surrogate systems. We will conduct following studies
to test our hypothesis: (1) Determine whether T. pallidum TprC, D2, and K proteins mediate attachment to host
cells in differential manner by recognizing the specific host receptors/ECM components on each cell type, and
(2) Determine the role of T. pallidum TprC, D2, and K proteins as channels involved in nutrient transport.
Significance: Our studies will lead to a better understanding of the molecular basis of T. pallidum adhesion to
host components, which is a pivotal step in congenital transmission and neuroinvasion during infection and will
provide important information to further support the use of these antigens as vaccine candidates in the future.

Public health relevance
PROJECT NARRATIVE Syphilis affects millions of people around the world and its global rates are on the rise. The disease causative agent, Treponema pallidum (T. pallidum) can cause serious neurological sequelae, and individuals with syphilis are at higher risk of transmitting and acquiring HIV. Understanding the biological functions of this pathogen's major virulence factors could help in developing new ways to prevent transmission of the disease and also have a profound and global impact on HIV prevention.